US RENAL DATA SYSTEM - SPECIAL STUDIES - ECONOMICS

The University of Iowa shall be serving as a Special Studies Center (SSCs) for the United States Renal Data System (USRDS). The major tasks of the Special Studies Center for Economics are to identify problems and opportunities for focused investigation, design and implementation of studies involving the use of existing USRDS data or the collection of new data, and the conduct of cost effectiveness studies and other economic studies of ESRD, in areas of significant interest. The Special Studies Center is responsible for working with the USRDS Coordinating Center, and will provide data to the Government.